Turning the TiDe: Training Diverse Clinician Scientists in Rehabilitation Research

The Training in Diversity education program, or TiDe, will transform the culture of rehabilitation research by
educating current rehabilitation clinician scientists in the skills and knowledge needed to recruit, train, and
support research trainees from populations underrepresented in biomedical science. TiDe will leverage
partnerships across disciplines and institutions to provide didactic and hands-on research experiences and
“training for the trainers” (current rehabilitation clinician scientists). These clinician scientists will in turn
support the next generation of diverse clinician scientists with the capacity to advance rehabilitation research.
The lack of diversity in science is problematic for several reasons, including limiting (1) the potential range of
diverse talent and perspectives needed to push science forward, (2) the breadth and depth of questions that are
asked, and (3) the generation of scientific outcomes that have the greatest potential impact for the entirety of
society. Given changing demographics in our society, it is more critical than ever that the health sciences
workforce reflects the true diversity of our citizens. Low diversity among the rehabilitation research workforce
is particularly problematic. The lack of racial, ethnic, and socioeconomic diversity among rehabilitation
students, practitioners, and faculty automatically reduces the potential pool of underrepresented rehabilitation
scientists. Further, the change to entry-level doctoral degrees for rehabilitation graduate professional programs
has increased education costs. These burdens risk even greater reductions in underrepresented personnel. To
address these needs, rehabilitation professions have launched a series of strategies to engage, matriculate, and
financially support underrepresented students in rehabilitation graduate professional programs across the nation.
Thus, graduate professional programs are currently the richest environment to recruit and train potential
future rehabilitation clinician scientists. Now is the time to augment these strategies and to create pathways
for underrepresented students to transition from professional to research training. Our program will “turn the
TiDe” and transform the extramural research climate by training current clinician scientists in best practices
for recruiting, training, supporting, and advancing future diverse clinician scientists. Current clinician scientists
need to learn how to create training environments that (1) embrace diverse talent and perspectives, (2) actively
combat the sense of isolation often experienced by underrepresented trainees, and (3) provide unbiased, genuine
mentorship and necessary financial support. TiDe will sustain the transformed research climate by investing
in diverse future clinician scientists who will enrich the breadth, depth, and impact of rehabilitation research.
TiDe will be led by rehabilitation scientists in top-ranked occupational and physical therapy research programs
at the University of Pittsburgh, the University of Delaware, Washington University, and Boston University.
TiDe will also partner with national professional and scientific organizations invested in training rehabilitation
clinician scientists who have agreed to provide personnel, resources, and funding to augment NIH R25 funding.

Public health relevance
The Training in Diversity education program, or TiDe, will transform rehabilitation research culture by educating rehabilitation clinician scientists in the skills and knowledge needed to train and support the next generation of underrepresented clinician scientists with the capacity to advance rehabilitation research.